Core 5

Core 5 will continue to be responsible for the dissemination of the MAGNet Center software platform, geWorkbench, and its associated tools and data. To achieve our goals, we will use outreach activities (conference presentations, training workshops, publications) and a significant and well established support infrastructure (project web site, user forums, expert support, collaborative development tools). These tools will help us proactively promote the Center's technologies and adoption by members of our dual target audience: biomedical researchers with varying degrees of computational skills and geWorkbench open-source component developers. Further, we will continue building on the success of our DREAM conference and challenges to critically assess the quality of Systems Biology tools and algorithms using objective experimental benchmarks, similar to what the CASP conference has achieved for the Structural Biology community.